Enabling Intranasal Therapies for Brain Invading Pathogens

The blood-brain barrier (BBB) plays the role of maintaining brain homeostasis and preventing foreign
invaders from infiltrating the brain tissue from the blood; however, an alternative pathway exists for
opportunistic pathogens to enter the brain and cause severe damage. Infiltrating either through the olfactory
or trigeminal nerves (in the nose), these pathogens, whether bacterial, viral, fungal, or parasitic, bypass the
BBB and cause devastating symptoms. Like brain tumors, these neural infiltrating pathogens are free to grow
with the protection afforded them by the BBB, which prevents the passage of greater than 98% of small
molecule drugs. Because of the difficulty associated with treatment, pathogenic infections can lead to
meningitis, with insufficient treatments available, demonstrated by mortality rates that range from ~10% to
98%, depending on the etiology. Although these pathogens vary in their etiology and pathology, many of
them are linked by enolase, an enzyme that plays a role in plasminogen binding and glucose metabolism,
which seems to enable their infiltration. The Larsen Lab is a leading expert in the development of
treatments for diseases of the central nervous system using polymer-based nanoparticles to
encapsulate and deliver drugs across the BBB. We will leverage this expertise towards the treatment of
brain-invading pathogens. Learning from these opportunistic pathogens, we will encapsulate enolase
inhibitors in polymer-based nanoparticles called polymersomes and deliver them via intranasal
administration. In this proposal, we specifically focus on brain-eating amoeba, or Naegleria fowleri, as our
first model to provide proof of concept for our approach due to its extremely high mortality rate. We plan to
leverage discoveries for treatments of other pathogens involving enolase.